Accessing the impact of youth suicide prevention program in small communities

Project Summary/Abstract
Suicide is a leading cause of death in the United States, particularly among youth aged 10–24 years. Youth in
smaller, more rural communities, particularly American Indian/Native American youth, face heightened risk.
Developing and delivering effective suicide prevention programs requires the means to rigorously evaluate
their impact. Conducting impact evaluations of suicide prevention programs faces many challenges common
to other fields, such as the difficulty in estimating the counterfactual when randomization is not feasible. These
challenges are further compounded by the difficulty of obtaining reliable estimates of suicide rates in
communities and segments of the population with heightened risk due to the small size of such communities.
Building on small area estimation techniques, Bayesian disease-mapping models were developed to improve
estimation of disease or health outcome rates in small areas by borrowing information from neighboring areas.
Despite their potential, these models have not been applied to program impact evaluation. This study has
three aims: (1) examine a method to assess suicide prevention impact in small areas with heightened suicide
risk; (2) identify particular conditions under which our proposed method can outperform alternative methods
for impact evaluation; and (3) extend earlier assessments of the impact of the Garrett Lee Smith (GLS)
Memorial youth suicide prevention program administered by the Substance Abuse and Mental Health
Services Administration by focusing on small, high-risk communities, such as tribal communities, that were
underrepresented in previous study samples.
This study will use both simulated and real data to empirically assess the accuracy of the proposed approach
vis-à-vis three alternative methods to estimate impact: synthetic control, elastic net, and matrix completion.
The simulated data will allow us to gauge how different levels of spatial and temporal dependence, as well as
variations in other relevant parameters, affect the relative performance of approaches. Finally, we will use a
sample of micropolitan and noncore communities exposed to the GLS program between 2006 and 2018 to
estimate the impact of the GLS program on both suicide and self-harm hospitalization rates among youth.
In sum, by applying Bayesian spatiotemporal models to suicide prevention impact evaluation, we expect to
both extend the utility of the approach beyond disease mapping and advance the ability to understand suicide
prevention programming impact in some of the highest-risk populations.

Public health relevance
Project Narrative When evaluating suicide prevention programs, the difficulty of obtaining reliable estimates of the outcome of interest in small communities and among segments of the population with heightened risk, including youth in rural communities or American Indian/Native American youth, compounds the usual challenges associated with assessing the impact of an intervention. We propose a novel approach for suicide prevention impact assessment in such settings, based on recent developments in Bayesian disease mapping, and will examine the performance of the approach using both simulated and real data from the Garrett Lee Smith youth suicide prevention program evaluation funded by the Substance Abuse and Mental Health Services Administration. If our findings reveal our approach to be accurate, this will provide an improved method to assess suicide prevention programming impact and will extend previous demonstrated impact findings to high-risk populations.